Photoreceptor Disease in Inherited Retinal Degenerations

PROJECT SUMMARY / ABSTRACT
Loss of eyesight is regarded among the worst possible diseases by most Americans. Despite being rare
causes of vision loss, inherited retinal diseases (IRDs) are molecularly simple single-gene defects, and
advances in genetics and genomics have raised hopes for the development of gene-based treatments. For
most IRDs, the natural history of disease involves progressive vision loss and successful interventions must
demonstrate a clinically meaningful slowing of the natural progression. Many good metrics have been
developed to measure vision loss but the continued lack of approved IRD treatments strongly suggest better
outcome measures are still needed. The long-term objective of the research is to predict retinal locations
maximally vulnerable to progression over the next 2 years individualized for each patient across distinct IRDs.
Successful predictions of loci of vulnerability will drive reliable measurements of functional and/or anatomical
changes over the duration of typical clinical trials. The focus of the current project is on two human IRDs that
remain without approved treatments – autosomal dominant retinitis pigmentosa caused by RHO mutations
(RHO-ADRP) and Stargardt disease caused by ABCA4 mutations (ABCA4-STGD). Average tendencies for
spatio-temporal progression in both diseases are well investigated. However, the reliable and individualized
prediction of the photoreceptor locations maximally vulnerable to fast progression remains a major challenge.
Current literature and preliminary studies support the hypothesis that retinal cross-sectional structure at each
location when considered together with the structure of its immediate neighborhood retains enough information
to predict vulnerability to disease progression. The current project will involve a combination of retrospective
longitudinal and prospective longitudinal studies that operate on different spatial scales and structure/function
dimensions, to test the hypothesis and provide a more complete understanding of the range of photoreceptor
vulnerability to disease progression in IRDs. Aim 1 will first use a unique existing data set obtained serially in
RHO-ADRP patients and train an artificial intelligence (AI) model to learn input OCT features that correspond
to disease progression. Trained AI will be applied to another unique existing data set obtained in ABCA4-
STGD patients. With special attention to heterogenous transition zones, retinal locations maximally vulnerable
will be mapped and validated against serial data. Aims 2 and 3 will use prospective serial studies in ABCA4-
STGD to test predictions directly with en face imaging, ultra-wide angle OCT recordings, microperimetric
evaluation of rod- and cone-specific light sensitivities, and novel adaptive-optics OCT imaging of the outer
retina. The project should provide novel insight into the interaction of human photoreceptors with their diseased
neighbors and allow optimum localization of visual function measurements to provide individualized and
sensitive outcome measures for ABCA4-STGD clinical trials.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Most common diseases afflicting human health result from complex combination of genetic, stochastic, behavioral and environmental factors interacting with age, whereas rare inherited retinal diseases (IRDs) are simpler single-gene defects that form the ideal basis for gene-based treatments. Despite decades of exciting progress, there is only one approved treatment for IRDs and a major contributing factor for this scarcity is the lack of biomarkers that can provide sensitive, reliable, and clinically meaningful measurement of photoreceptor degeneration over the duration of a typical clinical trial. This research plan is designed to fill this major gap for the most common molecular form of IRD which is Stargardt disease caused by ABCA4 mutations and forge a path to follow for other IRDs.